NIH BRAIN DEVELOPMENT COHORTS DATA SHARING PLATFORM. PERIOD OF PERFORMANCE 4/19/2024 - 4/18/2026.

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.